Contribution of G protein coupled estrogen receptor to changes in hypothalamic plasticity and hypertension susceptibility in mice with accelerated ovarian failure

Although the increase in hypertension and cardiovascular disease-risk at menopause is well-recognized, the
mechanisms of menopausal hypertension are still inadequately understood. Irregular cycles and declining levels
of estrogen have been suspected to play a critical role in the emergence of hypertension at the onset of
menopause. However, a clear understanding of estrogen’s role in menopausal hypertension has been limited
by the confounding effects of variables such as aging in the human literature and the use of models primarily
reliant on the use of ovariectomized animals that do not replicate natural menopause in the preclinical literature.
Significantly, a mouse model of accelerated ovarian failure (AOF) induced by 4-vinylcyclohexene diepoxide
(VCD) can recapitulate early (i.e., peri-AOF) and late (i.e., post-AOF) stages of human peri- and postmenopause,
respectively. The AOF model has proven effective in isolating the role of sex hormones in blood pressure,
particularly with respect to models of neurogenic hypertension involving the hypothalamic paraventricular
nucleus (PVN), a brain area critical for coordinating sympathetic and neurohumoral processes important for the
regulation of blood pressure. In the last grant award, we found that peri-AOF hypertension induced by slow-
pressor angiotensin II (AngII) was associated with a signaling pathway involving estrogen receptor beta (ERb)
and the NMDA-type glutamate receptor in PVN neurons. It is important to recognize that after perimenopause
women transition to postmenopause, however, it is unclear if the mechanisms of hypertension during
postmenopause are mediated by similar mechanisms. In pilot data, we show that hypertension at post-AOF is
associated with altered signaling involving GluA1-expressing AMPA, but not NMDA receptors. We further show
that administration of an agonist of the G-protein coupled estrogen receptor 1 (GPER), but not ERb, inhibits
AngII hypertension in post-AOF mice. In this proposal, we will test the central hypothesis that post-AOF mice
are predisposed to hypertension that is dependent on GluA1 plasticity in the PVN and alleviated by GPER
signaling. Two aims will test this hypothesis. Aim 1 tests the sub-hypothesis that alterations in PVN GluA1
signaling contribute to hypertension in post-AOF mice. Aim 2 tests the sub-hypothesis that post-AOF
hypertension is associated with GPER signaling in the PVN. These studies will be performed using a
combination of approaches including high-resolution anatomical, neurophysiological, in vivo gene targeting, and
single-cell RNA sequencing approaches.

Public health relevance
RELEVANCE Although the risk of hypertension increases in women at menopause the biological mechanisms underlying this increased hypertension susceptibility is uncertain. Using a multidisciplinary strategy incorporating sophisticated approaches we will investigate the brain mechanisms of menopausal hypertension using a novel model of accelerated ovarian failure in mice. A better grasp of the mechanisms underlying the emergence of hypertension associated with ovarian failure will aid in developing more effective diagnostic and therapeutic strategies for the gender-specific management of blood pressure.